A Novel Epigenetic Editing Platform

CRISPR-based gene editing has become mainstream in its popularity because of its approval as a therapeutic.
Yet, concerns about safety persist since CRISPR-based therapeutics result in permeant changes to the DNA
sequence, which are irreversible if side effects arise. Epigenetic editing, manipulation the epigenome in a
targeted way to alter gene expression, in contrast, has become an interesting alternative since it avoids
permanent changes of DNA sequences. However, epigenome editing is an immature field with limited tools
available. Options include fusion of epigenetic modifying enzymes to sequence specific DNA targeting proteins
such as TALEs and Zinc Fingers or a version of CRISPR that uses an enzymatically dead Cas protein. All of
these approaches have limitations including, difficulty in design with extensive cloning effort, variability in
binding affinity, off-target editing and delivery challenges based on the large size of the targeting proteins. In
this proposal we describe a new epigenetic editing platform that uses a completely novel targeting approach
for recruitment of epigenetic effectors to specific genomic loci resulting in targeted alterations to the epigenetic
landscape and directed changes in gene expression. This platform will initially be developed as a research
use only tool but, in the long term, has the potential for use in a therapeutic setting.

Public health relevance
We propose a novel epigenetic editing platform called SEETHR (Simplified Epigenetic Editing Through Hybridization to R-loops) to overcome limitations of existing epigenetic editing systems.